VA Biorepository Brain Bank

Amyotrophic lateral sclerosis (ALS) is a largely adult-onset, progressive, fatal (death usually occurring in 3-5
years) neurodegenerative disease with a multifactorial etiology and a heterogenous clinical presentation. There
are numerous genetic and non-genetic risk factors, with new ones discovered frequently. Among the non-
genetic risk factors, age, male sex and several environmental factors, including military service, are the most
salient. Accordingly, ALS is a fully compensable condition in the Department of Veterans Affairs (VA) Veterans
Health Administration (VHA). As the Veteran population ages, the incidence and prevalence of ALS, with its
staggering personal, financial and societal costs, will continue to increase. Establishing large national cohorts
essential for ALS research is limited by the low prevalence (6-8 cases per 100,000) and short survival time (3-5
years) of persons with ALS (PALS). This is particularly true for efforts to develop biorepositories that collect
central nervous system (CNS) tissue samples annotated with clinical information essential to biomedical ALS
research. Although a number of mouse models have been developed to study ALS, these models are limited
and the need for research quality human CNS tissue for genomic and proteomic research in ALS is critical.
The VA funded the VA Biorepository Brain Bank (VABBB) to support ALS research and improve clinical care.
The VABBB is presently the only national prospective cohort study and CNS tissue bank in the U.S. that is
enrolling and conducting ongoing follow-up on Veterans with ALS. The VABBB is a multi-site collaboration
among VA Boston Healthcare System (VABHS) and the Southern Arizona VA Healthcare System (SAVAHCS).
The VABBB utilizes the strengths across the Boston and Tucson sites in enrollment, assessment, tissue
banking operations, neuropathological diagnosis, medical informatics and data management. The VABBB
cohort is notable for its size (over 300 PALS), the amount and quality of CNS tissue and clinical data available,
and for the relatively long duration and slow disease progression in this unique cohort. Tissue and clinical data
from the VABBB are available for distribution to qualified researchers. In this application, we seek to further our
support of cutting-edge ALS research and enhance the value of VA’s investment in the VABBB. Over the next
four years our specific aims are: 1) To continue, and further enhance, the VA Biorepository Brain Bank
(VABBB) as the nation’s only national prospective cohort study and central nervous system (CNS)
tissue/biofluid bank supporting international ALS research; 2) Conduct state-of-the-art diagnostic
neuropathological evaluation; and 3) To continue our characterization of cognitive and behavioral dysfunction
in our cohort to support emerging clinicopathological studies of ALS and frontotemporal lobar degeneration.
Specific Aim 1 will involve 1) generation of a larger and more diverse (e.g., sex) national sample of Veteran
PALS and controls; 2) enhanced antemortem biofluid (e.g., blood) and postmortem tissue (e.g., bone, muscle)
collection and analyses (e.g., whole genome sequencing); and 3) conduct in-depth clinical characterization of
our large cohort of long duration (>10 years) PALS. In Specific Aim 2, we will 1) establish comprehensive
neuropathological diagnoses on all brains using strict diagnostic criteria; 2) prepare and store CNS tissue in
optimal conditions (including pH and RNA), 3) maintain an extensive neuropathological database to
accompany banked tissue; providing clinicopathological correlation, and 4) communicate the neuropathological
results to family members when requested. Regarding Specific Aim 3, we will continue our telephone/mail
assessments to improve the cognitive/behavioral characterization of our cohort. There is consensus that
cognitive/behavioral dysfunction in ALS is related to the genetics and neuropathology of the disease. We aim
to facilitate clinicopathological studies of the ALS-frontotemporal lobar degeneration (FTLD) continuum by
providing cognitive/behavioral data with genetic and neuropathology data – another unique aspect of the
VABBB.

Public health relevance
Amyotrophic lateral sclerosis (ALS) is an incurable fatal neurologic disease leading to progressive paralysis and, in many cases, cognitive decline. There is no effective treatment for ALS and its ultimate cause remains unknown. Because studies suggest that veterans are at increased risk for ALS, VA established ALS as a 100% service-connected disability. VA has made a major commitment to support research on ALS and funded the creation of the VA Biorepository Brain Bank (VABBB) as a national resource to support ALS research. Enrolled veterans with ALS across the country receive semi-annual telephone calls to collect health information. Upon a veteran’s death, the VABBB arranges for the collection of brain and spinal cord tissue for processing, storage, and distribution to qualified ALS investigators. The availability of high-quality tissue and clinical data from veterans enrolled in the VABBB is an essential resource to support research on the causes and effects of ALS and the development of effective treatments for those affected by this devastating disease.